2/2 Howard-Georgetown Collaborative Partnership in Cancer Research

Overall Abstract
The overarching goal of the NCI Collaborative P20 Partnership in Cancer Research is to enhance cancer
research capacity at Howard University and increase participation in cancer health disparities research at
Georgetown Lombardi Comprehensive Cancer Center (GU). The Partnership goals will be achieved through
two primary mechanisms: pilot research projects and cancer research education. The P20 will benefit from the
guidance of an Internal Advisory Committee (IAC) made up of highly qualified and experienced scientists. The
Research Pilot Projects will fund four 2-year collaborative research pilot projects. Each project will include at
least one investigator from Howard and one from Georgetown. The investigators will benefit from the HU/GU
CTSA and the Shared Resources available at GU. Pilot project 1 will identify candidate genes and genetic
pathways associated with Non-Alcoholic Fatty Liver Disease (NAFLD). The research will inform possible
biological mechanisms underlying the molecular and genetic signatures of perturbed metabolic and mechanistic
pathways in NAFLD patients in an African–American population. Results may lead to innovative non-invasive
biomarkers. Research Project 2 will investigate disparities in chronic stress, quality of life, and physical activity
among Black and White breast cancer survivors. This study will provide insight into whether an association exists
between physical activity and allostatic load in breast cancer survivors. During the course of the award, the P20
Partnership will elicit two additional pilot studies through a competitive process which will be driven by a merit
review by the IAC. The expected outcome of the pilot projects is the submission of successful collaborative grant
applications supported by the preliminary data obtained via the pilot research. The C-REP will contribute to the
goals of the Partnership by engaging a diverse group students and faculty who are under-represented as
investigators in biomedical research. A cohort consisting of a mix of college students in their junior or senior
year, graduate and professional students will be recruited annually for an intensive 8-week mentored summer
research experience. Follow-up mentoring will be provided to promote entry into a graduate or professional
program or postdoctoral research training. Postdoctoral fellows and faculty will receive training and mentoring
to support attaining a robust, high quality publication record and submission of highly competitive independent
research proposals. Mentoring within the C-REP will occur via teams of at least one faculty member from both
institutions. The Howard-Georgetown P20 Partnership brings many strengths including a large pool of under-
represented students and faculty at Howard University, extensive research resources through GU, and a
foundation of longstanding, productive partnerships between the two institutions.

Public health relevance
Overall Project Narrative This project is a collaboration between Howard University, a Historically Black University and Georgetown University, a Comprehensive Cancer Center. This partnership will support cancer research studies to provide information that will be useful to advance cancer knowledge and continued research in cancer disparities related fields. Through mentoring, education, and research experiences, we intend to increase participation in cancer research from individuals who are under-represented in the research field.